Pharmacological inhibition of the cystic fibrosis transmembrane conductance regulator (CFTR)

PROJECT SUMMARY/ABSTRACT
Autosomal dominant polycystic kidney disease (ADPKD) is the most common inherited kidney disease
and fourth leading cause of end-stage renal disease (ESRD). Hyperactivation of the cystic fibrosis
transmembrane conductance regulator (CFTR) is essential for cyst formation and enlargement in ADPKD, and
inhibition of CFTR is a potential therapeutic strategy. Despite its importance as a pharmacological target, the
conformations transited by CFTR during physiological gating are poorly resolved, and the mechanism by which
nucleotide state is communicated from the nucleotide binding domains (NBDs) to the pore 50 Å away remains
obscure. Additionally, molecular mechanisms of pharmacological inhibition have been understudied despite
therapeutic promise for ADPKD. Specific aim 1 seeks to determine the structural basis of allosteric
communication between the NBDs and the pore using cryogenic electron microscopy (cryo-EM). Specific aim
2 seeks to determine the mechanisms of existing pharmacological inhibitors of CFTR using cryo-EM in
combination with electrophysiological, biochemical, and biophysical assays. Specific aim 3 seeks to find new
inhibitors of CFTR to enhance treatment of ADPKD using computational docking and medicinal chemistry
coupled with high-throughput assays, electrophysiology, and mouse models of ADPKD. Successful completion
of these goals will fill a gap in our understanding of the CFTR gating cycle, provide new conformations for
pharmacological targeting, expand our understanding of CFTR’s pharmacological regulation, and establish new
leads for treatment of ADPKD.
The proposed research strategy will be completed under the mentorship of Dr. Jue Chen in the Laboratory
of Membrane Biology and Biophysics at The Rockefeller University (RU) in New York City with the co-advisement
of Dr. Jiankun Lyu at RU. The accompanying fellowship training plan will be completed through the Tri-
Institutional MD-PhD Program of Weill Cornell Medicine, The Rockefeller University, and Memorial Sloan
Kettering Cancer Center. The exceptional clinical and scientific resources of these environments will facilitate
successful completion of both research and training components. The electrophysiological, biochemical,
biophysical, and structural biology equipment and expertise available at The Rockefeller University is
unparalleled, and trainees are encouraged to collaborate with other scientists and institutions in New York City’s
rich structural biology research network. The Tri-Institutional MD-PhD Program offers a diversity of clinical,
research, and extracurricular opportunities for trainees to develop the analytical, technical, communication, and
mentorship skills necessary to become independent physician-scientists. Trainees are encouraged to
continuously develop their clinical and scientific skills through both medical and graduate phases of the MD-PhD
curriculum. This curriculum is supervised by a supportive administration that provides ample guidance for
trainees to pursue productive careers promoting the health of the American public.

Public health relevance
PROJECT NARRATIVE Autosomal dominant polycystic kidney disease (ADPKD) is the most common heritable kidney disease and the fourth leading cause of end-stage renal disease. Hyperactivation of the cystic fibrosis transmembrane conductance regulator (CFTR) is essential to cyst formation and enlargement in ADPKD, and CFTR inhibition holds therapeutic potential. This proposal seeks to resolve the conformational landscape of CFTR during its physiologic gating cycle, characterize the mechanisms of existing CFTR inhibitors, and discover new allosteric inhibitors; completion of the proposed work will lay a foundation for development of new treatments for ADPKD.